5th Annual SMRU Traveling Scholar Award

DESCRIPTION (provided by applicant):The 5th Annual Society for Male Reproduction and Urology (SMRU) Traveling Award will be held in conjunction with the 58th Annual Meeting of the American Society for Reproductive Medicine (ASRM) in Seattle, WA, from October 12-17, 2002. The primary objective of the SMRU Travel Award is to stimulate the scientific interests of residents and fellows in the study of male reproductive medicine by providing a structured didactic program of education. Ten physicians and basic science researchers in training, who will all present an abstract at a podium or poster session, will participate. Formal lectures include "Evaluation of the Infertile Male" by Dr. Jay Sandlow, "Fertility in the Spinal Cord Injured Male" by Drs. Nancy Brackett and Charles Lynne, and "Vasectomy Reversal: Tricks of the Trade" by Dr. Harris Nagler. Participants will attend the two-day post-graduate course organized by the SMRU, a roundtable luncheon, and SMRU workshops and seminars.